Modernizing Perinatal Syphilis Testing

Abstract
The re-emergence in maternal and congenital syphilis (CS) infection in recent years has brought
this sexually transmitted infection (STI) to the forefront of policy discussions among federal and
state health and human services departments. The recommended tests at birth demonstrate poor
sensitivity for the diagnosis of CS, necessitating longitudinal follow up for up to 18 months until
infection can be definitively excluded. This strategy inevitably results in cases of delayed or even
missed treatment, leading to serious adverse outcomes that could have been prevented. With data
suggesting a missed diagnosis rate approaching 15%, there is an urgent need for improved
diagnostic modalities to detect CS through direct identification ofT. pallidum using highly
sensitive contemporary nucleic acid amplification tests (NAA Ts). Two potential options include:
real-time quantitative polymerase chain reaction (qPCR) and the Aptima Treponema pallidum
transcription-mediated amplification (TMA) assay. By directly detecting the pathogen in
neonatal biospecimens, these assays may provide more timely detection of CS in order to initiate
timely evaluations and treatment. The aim of this study is to conduct a large, multicenter,
prospective observational cohort trial of 924 maternal and neonatal dyads at risk for CS to
effectively evaluate the test performance of these NAATs compared to the 2021 STD CS
infection categories assigned to that patient at birth ( confirmed proven/highly probable, possible
CS, CS less likely, CS unlikely) to determine if a superior diagnostic algorithm exists.
Longitudinal follow up confirming infection status will be performed up to 18 months of age.
Based on existing scientific premise, our central hypothesis is that the contemporary NAA Ts will
result in a more sensitive, specific and timely diagnosis of congenital infection with T. pallidum
compared to the standard recommended testing algorithms. In addition, we plan to leverage the
resulting clinical cohort to more accurately define adverse neurodevelopmental outcomes
associated with CS. This study will be the first to evaluate neurodevelopmental outcomes of
affected children by performing Bayley Scales of Infant and Toddler Development™ at 18
months on the offspring of infected women. Beyond the importance of this research in terms of
pure science, the results could have far-reaching public health implications that may contribute to
improved quality and guideline efforts.

Public health relevance
Project Narrative The primary objective of this multicenter prospective cohort trial is to effectively evaluate the test performance of novel molecular techniques for the diagnose of congenital syphilis (CS). It is hypothesized that contemporary molecular platforms will result in more sensitive, specific and timely diagnosis of congenital infection with Treponema pallidum compared to the current CDC diagnostic standards. In addition, we plan to leverage the resulting clinical cohort to more accurately define adverse neurodevelopmental outcomes associated with CS.